Mucosal Immunology Course & Symposium (MICS)

As the degree of interest in mucosal immunology continues its upswing, the SMI has decided to initiate a second set of biennial meetings to be called “Mucosal Immunology Course and Symposium” that will be held in even?numbered years. These meetings will include a full day course aimed mainly at trainees preceding the main meeting, which will be organized as a symposium emphasizing a prominent and active area from within the broad area of mucosal immunology. The first SMI?sponsored MICS meeting will be held in Toronto from July 26–30, 2016. The content of this meeting will focus on the educational theme of “Microbiota and Mucosal Immunity: Rules of Engagement in Health and Disease”. The breadth of research into the nature and function of the commensal microbiota has surged in recent years. Most of the human microbiota is resident at one of the major mucosal surfaces, including the gastrointestinal tract, the upper and lower respiratory tract, and the genitourinary system. Thus there is a natural scientific interface between studies of the microbiota and studies of mucosal immunology. Scientific sessions will promote excellence in research and education across many areas of mucosal immunology and microbiota studies and will foster increased communication and scientific collaboration among immunologists and microbiota researchers. MICS 2016, co?chaired by Drs. Ifor Williams, Phil Smith, Dana Philpott, Ken Croitoru, and Gerard Eberl, will deliver another exciting program of wide interest to mucosal immunologists. The meeting includes 17 keynote and plenary speakers who will present new information in areas relating to influence of the microbiota on asthma and allergies, secretory IgA and the mucosal microbiota, the microbiota and gut immune system development, intestinal microbiota and inflammatory bowel disease, mucosal immunity to urogenital microbiota and therapeutic modulation of the human gut microbiota. These sessions will be enhanced by an additional 20 invited speakers who will chair abstract?driven sessions on antigen uptake, asthma and atopic disease, bioinformatics analysis of microbiota, celiac disease, dendritic cells, diet, nutrition and microbiota, effector T cells and cytokines, epithelial cells in innate immunity, fecal microbiota transplantation, food allergy, gastric microbiota, genitourinary microbiota, HIV, IgA responses to microbiota, inflammatory bowel disease, innate immune responses, innate lymphoid cells, intestinal microbiota, microbial ecology of mucosal surfaces, monocytes and macrophages, mucosal B cells, mucosal infections, mucosal tolerance, mucosal vaccines and probiotics. The educational content of MICS 2016 was developed by SMI's International Planning Committee, which is comprised of leaders in the mucosal immunology field. As experts, committee members engaged in discussions in which topics are identified and developed into sessions. Committee members drew from their extensive knowledge, and also consulted membership surveys and conducted after previous SMI meetings to create a program that addresses timely topics in mucosal immunology with a strong emphasis on interactions between the mucosal immune system and the microbiota resident at mucosal surfaces. In addition to highlighting the best science, MICS 2016 will also be an incubator for developing scientists and practitioners alike to meet with one another along with representatives of relevant biotechnology and pharmaceutical industry. The meeting includes 3 days of oral abstract presentations and 2 evening poster sessions to give young investigators the change to have their work presented and critiqued. SMI takes a specific interest in the development of young investigators and provides travel awards to them to supplement their costs to attend the meeting.

Public health relevance
MICS 2016 Project Narrative While most immunologists typically study immune responses in the spleen, lymph nodes or blood, mucosal immunologists focus on the sites in contact with the external environment which are exposed to continuous antigenic bombardment. The principal tissues involved are the gut and the lung, but there is also major interest in the upper respiratory tract, urogenital tract and the eye. These surfaces are important as the first line of defense against an array of pathogenic microbes, and remarkably, the mucosal immune system in health can distinguish between pathogens, the commensal flora and innocuous dietary antigens, and mount an appropriate response to each type of challenge. The gut is also the major lymphoid organ in the body, containing the majority of antibody secreting cells and 70 percent of the lymphoid tissue. Deciphering the cues which separate tolerance from effective immunity at mucosal surfaces lies at the core of mucosal immunology. The corollary of this, however, is that many pathogens successfully colonize mucosal surfaces, or use mucosal surfaces to enter the tissues, so elucidating how these pathogens do this, and the mechanisms of effective immunity remain important. At the same time, the challenges of protecting mucosal surfaces from infection through vaccination immediately come up against the problem of tolerance. The revolution in mucosal immunology/microbiology in the last few years is evidence of the appreciation of the important role of the commensal flora in mucosal immunity. The central role of the microbiome in health and disease is now being fully recognized. At the same time, while it has been long appreciated that inappropriate tissue damaging immune responses can occur to foods such as wheat and cow's milk, it is now obvious that inappropriate immune responses, often genetically determined, are involved in inflammatory bowel disease. The MICS educational initiative is based on recent research and data regarding documented unmet medical needs in the field of mucosal immunology and microbiota studies. Since 1990 mucosal immunology has expanded from what many considered a niche discipline to one of the hottest areas in immunobiology today. PubMed includes 1959 articles on “mucosal immunology” published between 1981 and 1990; between 1991 and 2000 that number grew to 6280; between 2001 and 2010 the same search yielded 10824 articles. This rapid growth trend has continued in the current decade with 7202 articles listed in PubMed from 2011 through the end of 2015.